CORE--STATISTICAL

Statistical consultation will be provided in a substantial manner to two of the projects (White, Project 1 and Weiss, Project 5) and will always be available to the remaining three projects. Dr. Hurwitz has met with each investigator in the SCOR during the evaluation of the proposal and has addressed all necessary issues (sample size, study design, appropriate statistical testings, etc.). She will continue throughout the proposal, to [provide such statistical assistance.